Graduate Training in Cellular and Molecular Pathogenesis of Human Diseases

PROJECT SUMMARY/ABSTRACT
The Cellular and Molecular Pathology (CMP) Graduate Training Program is a joint venture of the University of
Wisconsin (UW)-Madison Graduate School, the Department of Pathology & Laboratory Medicine and the
School of Medicine and Public Health (SMPH). CMP provides rigorous didactic training in fundamental basic
biomedical sciences combined with interdisciplinary and innovative training in the pathogenesis of major
human diseases. The goal of the CMP program is to create a stimulating and robust intellectual environment
for predoctoral training embedded in a dynamic basic and clinical translational research atmosphere in order to
develop the skills needed to move biological knowledge toward clinical application. Biomedical Graduate
Training for the future demands that first rate academic scientists graduate with appropriate operational,
technical and professional skills that will position them for diverse bioscience careers in academia, industry
or government. The primary mission of the CMP program is to answer this demand and prepare our
graduates for productive careers in the rapidly evolving biomedical research field. The program provides
operational (in-depth knowledge, rigorous and reproducible experimental design, critical thinking), technical
(teaching state-of-the-art methods, rigor and reproducibility) and professional (career development, IDPs and
other opportunities) skills to ensure student success. The overall objective of CMP is to educate trainees so
that they have a fundamental knowledge of pathology and molecular medicine, and have an in-depth research
experience that combines pathobiological and translational clinical research. CMP’s specific objective is to
ensure optimal PhD completion rates and time-to-degree with the implementation of monitored IDPs, student
success and progress monitoring. CMP objectives will integrate measurable outcomes the program intends to
achieve, such as appropriate completion rates, career placement outcomes and student retention rates. The
Program draws 85 PhD, MD/PhD or MD funded faculty trainers from 24 departments. We are requesting
training of eight pre-doctoral students under the Molecular Medicine Program. Trainees will be supported in
the first or second year of their training. Candidates will be selected based on commitment to research
documented by research experience, letters of recommendation and the potential to enhance diversity and
make significant contributions toward the health-related research needs of our nation. Our curriculum provides
interdisciplinary and integrated training in fundamental concepts in modern pathobiology with an emphasis on
biochemical, cellular and molecular approaches to the study of human disease, including training in statistics,
rigor and reproducibility and responsible conduct in research. CMP helps students to develop teaching and
leadership skills through committee service, presentations and workshop teaching. The proposed program
provides the fundamental knowledge base, research experience, and understanding of translational clinical
research necessary for the success of our graduates.

Public health relevance
PROJECT NARRATIVE Graduate science education plays a critical role in the success of the U.S. workforce and economy, attracting and producing a diverse work force of researchers, innovators, educators, and leaders. We developed an innovative graduate program relying on the traditions and experience of one of the oldest pathology training programs in the country, but incorporating creative approaches to provide operational (cutting edge in-depth knowledge), technical (state-of-the-art methodology) and professional (transition into careers) skills that will lead to the output of true translational, diverse scientists. The Cellular and Molecular Pathology (CMP) graduate training program at the University of Wisconsin provides rigorous didactic training in fundamental basic biomedical sciences combined with interdisciplinary and innovative training in the pathogenesis of major human diseases. According to the Commission on Pathways Through Graduate School and Into Careers, “between 2010 and 2020, about 2.6 million new and replacement jobs are expected to require an advanced degree, with a projected increase for jobs requiring a doctorate or professional degree” (www.pathwaysreport.org). The primary mission of the CMP program is to prepare graduates for diverse productive careers in biomedical and clinical research, education, industry or government and to position them to make significant contributions toward the health-related research needs of our nation. The CMP program provides graduate students with interdisciplinary and integrated training in the pathogenesis of human diseases with emphasis on molecular, cellular and biochemical approaches. We seek to increase each individual student's appreciation of how specific disease processes directly impact individual patients, while fostering the application of the student's specific research area to potential new concepts in clinical care and treatment. As basic and clinical sciences have evolved, new approaches to apply multidisciplinary knowledge in the field of medicine are required. The CMP graduate program is unique in that it encompasses both basic and clinical research, thereby providing the highest quality graduate education to the next generation of biomedical scientists.